Understanding metabolic vulnerabilities in cancer and the impact the tumor microenvironment has on cancer progression.

Project Summary
This proposal seeks to understand the impact of metabolism on cancer aggressiveness, and how metabolic
vulnerabilities can be targeted to improve patient outcome. Although targeted therapies have a great focus in
the cancer research community, they have failed to generate durable responses, because of the emergence of
resistance and the evolution of cancer. Metabolism is exquisitely sensitive to perturbations in the
microenvironment, and this is currently an under-investigated area in cancer research. Successfully targeting
metabolism has the potential to benefit patients across multiple cancer types, and genotypes, which until now
has been a challenge. Cancer preferentially consumes glucose even in the presence of adequate oxygen
(aerobic glycolysis), which results in the lactic acid production that decreases extracellular pH. In this Ph.D.
project, it is hypothesized an alternative explanation for aerobic glycolysis, also known as the Warburg Effect
(W.E), is that the enhanced uptake of glucose is due to the expression of acid exporting membrane
transporters. Carbonic anhydrase IX (CA-IX) is one such acid producing protein, which we hypothesize leads
to an intracellular proton deficit, driving the fermentation of glucose to replenish the deficit. CA-IX is a clinically
relevant protein upregulated in numerous cancers, including breast and ovarian. CA-IX has an exofacial active
site that reversibly hydrates CO2 into HCO3- and H+, and we term it a pseudohypoxic protein, as although
regulated by hypoxia it is often expressed under normoxic conditions. In Aim 1.1 (prior studies), we have
shown that CA-IX, or PMA1(yeast proton ATPase), over-expression in a lowly aggressive, non-metastatic
breast cancer cell line (MCF-7) increases the glycolytic rate, glucose uptake, lactate production and increases
lung metastasis in vivo. We also developed a metabolic profiling tool to compare 2D and 3D metabolism in the
Seahorse Extracellular Flux Analyzer to aid us in our metabolic studies. Finally, preliminary pHi studies show
our CA-IX clones have a higher intracellular pH compared to parental MCF-7. In Aim 1.2, (proposed studies),
we will take more robust measurements of intracellular pH in both CA-IX and PMA-1 clones at various
extracellular pH. We will also measure CA-IX enzymatic activity in the presence and absence of a CA-IX
inhibitor from Philogen. We will repeat our in vivo tail vein experimental metastasis studies in the presence and
absence of sodium bicarbonate (buffer therapy), and the CA-IX Philogen inhibitor, to see if it reduces
metastasis. Finally, in Aim 2, the post-doc will focus on understanding the metabolic phenotype of small cell
lung cancer (SCLC). The work will be translationally focused to aid in the treatment of patients. SCLC has a
very poor prognostic outcome and, currently, its metabolic vulnerabilities are untapped. Using 13C-labelled
metabolite studies in vivo and through patient needle biopsies, we hope to elucidate those metabolic pathways
aiding in aggressiveness of the disease. Overall, the focus of my career is to understand the impact of cancer
cell metabolism on patient outcome and therapy resistance to clinically benefit patients.

Public health relevance
Project narrative This grant will enable me to answer fundamental questions about proton producing proteins and their role in, not only driving metabolism and metastasis in cancer but how their activity causes a proton deficit leading to upregulation of glycolysis. Secondly, through the post-doc project, I will gain insight into small cell lung cancer metabolism and how this can be targeted therapeutically. Further understanding of cancer metabolism can benefit a wide range of patients due to applying to numerous cancer types and genotypes and the more people that can be helped, the better.